Protective impacts of commensal protists on the human gut microbiome

PROJECT SUMMARY
The human microbiome is a rich ecosystem that contains microbes from all domains of life, including bacteria,
archaea, and eukaryotes such as fungi and protists. The gut microbiome exerts an important influence on the
immune system, both in healthy and disease states. While the bacterial components of the microbiome have
been well studied, little is known about the eukaryotic fraction. Eukaryotic protists, such as Blastocystis, are
commonly found in the human gut. A growing body of evidence demonstrates that these commensal protists
remodel the gut bacterial community and protect the host from gut inflammation, though the mechanisms of
these actions remain completely unknown. These observations are at odds with traditional medical views that
these protists are pathogenic; indeed, samples containing them are excluded from fecal microbiome transplant
therapies due to a belief that they are harmful. Very little is known about the biology of commensal gut protists,
including their genome sequences and how they interact with microbiome bacteria or the human host. In this
proposal, high quality genomics of the most common human commensal protist Blastocysis will be established
and two mechanisms of interaction with the microbiome and host will be investigated: bacterial predation and
metabolite production. In Aim 1, high-quality, contiguous, and well-annotated genome assemblies of multiple
Blastocystis subtypes will be generated. These high-quality assemblies will be used to determine the core and
pan-genome content of the species and reveal functional pathways specific to individual subtypes that contribute
to their microbiome functions. Using these genomes in combination with shotgun metagenomic sequencing will
reveal whether this organism reproduces sexually. In Aim 2, the hypothesis that Blastocystis are bacterial
predators will be tested through co-culturing experiments with bacteria identified to co-occur and co-exclude with
these protists in the gut microbiome. In Aim 3, the small molecule repertoire of Blastocystis will be determined in
vitro and in vivo, and how this organism influences the host-facing metabolome will be established. These
experiments will further establish a rich source of metabolic data for future functional studies of host interactions.
The work proposed here will establish gut commensal protist genomics and reveal fundamental mechanisms by
which these organisms interact with the host and bacterial members of the microbiome. These findings have
potential to indicate protists or their metabolites for use as probiotic interventions in inflammatory bowel diseases.
The proposed work in this proposal will leverage the candidate’s expertise in the field of microbial eukaryotes
with an expert interdisciplinary scientific advisory committee, enabling the candidate to establish a successful
independent research program.

Public health relevance
PROJECT NARRATIVE Commensal gut protists shape the bacterial composition of the human gut microbiome and protect against inflammatory bowel diseases. However, how protists interact with other microbes and contribute to the gut metabolic environment to cause these outcomes are unclear. This work will use genomics and defined culture- based approaches to determine mechanisms of protist-bacteria and protist-host interactions, with the potential to support the use of commensal protists and their metabolites in therapies.